Understanding the context-dependent roles of mutations in lymphoma.

DESCRIPTION (provided by applicant): Recent work from our group and others has provided a wealth of information regarding the genetic makeup of lymphomas and other tumors. However, it is unclear how these genetic mutations actually cause the disease and the degree to which they are associated with known biological processes and outcome. In this proposal, we seek to study how different genetic mutations are associated with known lymphoma phenotypes and the context-dependent roles of genetic mutations.

Public health relevance
PUBLIC HEALTH RELEVANCE: High throughput sequencing and microarrays have provided new opportunities for unravelling tumor biology by the enumeration of differential mutation and/or expression of genes and oncogenic pathways. In this proposal, we develop a novel approach to better understanding the role of individual genes in the context of lymphomas. This knowledge is essential to the identification of better therapies in these patients.